The effects of obesity and GLP-1R/GIPR agonists on early-onset breast cancer risk

PROJECT SUMMARY/ABSTRACT
The global rise in early-onset breast cancer (EOBC), particularly in women under 40, is an urgent and poorly
understood public health concern. EOBC often presents as aggressive subtypes in women without known
genetic predispositions. While obesity is a well-established risk factor for postmenopausal breast cancer, its role
in EOBC remains unclear. This gap is exacerbated by the lack of physiologically relevant preclinical models that
integrate age, obesity, and mammary gland biology—factors critical to studying early tumorigenesis.
Obesity is characterized by chronic low-grade inflammation and systemic metabolic dysfunction, both of which
promote a tumor-supportive environment. Modulating these effects through calorie restriction, fasting, or bariatric
surgery has shown promise, yet clinical translation is limited by adherence and sustainability. Recently, GLP-
1R/GIPR agonists have emerged as a safe and effective pharmacologic intervention for weight loss in obese
patients. However, their potential to reverse obesity-driven cancer risk, especially in EOBC, remains largely
unexplored.
We hypothesize that diet-induced obesity accelerates mammary tumorigenesis in EOBC, and that GLP-
1R/GIPR agonists can mitigate this risk by restoring metabolic balance and reprogramming immune responses.
Preliminary results demonstrate that obesity enhances tumor development, while treatment with the dual agonist
tirzepatide reverses this effect.
To test this, we will utilize two unique, immune-competent genetically engineered mouse models (GEMMs)
developed in our lab that recapitulate HER2⁺ and triple-negative subtypes commonly seen in EOBC. These
models allow precise temporal control of tumor initiation, aligned with the clinical window of disease onset in
women. Aim 1 will define how obesity and GLP-1R/GIPR agonists affect tumor initiation, progression, and
metastasis. Mice will be rendered obese via high-fat diet prior to tumor induction and randomized to receive
tirzepatide or vehicle. Tumor dynamics will be tracked using bioluminescence imaging and ex vivo analyses.
Aim 2 will uncover systemic and tumor-intrinsic mechanisms that mediate differential tumor responses across
lean, obese, and weight-loss conditions using immunofluorescence, flow cytometry, and serum metabolomics.
Together, these studies will elucidate the impact of obesity and weight-loss therapy in early-onset breast cancer
risks and progression and pave the way toward understanding the underlying mechanisms thereof.

Public health relevance
Project Narrative Breast cancer incidence among women under 40 has risen substantially in recent years. While this trend may be partially driven by the obesity epidemic, clinical evidence remains limited, and preclinical models that accurately reflect early-onset breast cancer are lacking. Leveraging unique, immune-competent models that recapitulate all stages of early-onset breast cancer, this project aims to investigate the mechanistic relationship between obesity, drug-induced weight-loss and early-onset breast cancer risks, with the eventual goal of elucidating actionable molecular targets for prevention and treatment.